EFFECTS OF DEXTROMETHORPHAN, NALOXONE &FENTANYL ON EXPERIMENTAL PAIN

The purpose of this study is to determine which kinds of brief tolerable experimental pain are affected by Dextromethorphan, Naloxone and Fentanyl.